A microscope for ultra-high multiplex spatial imaging of transcripts and proteins in tissues

In this proposal, 13 NIH-funded faculty from the Massachusetts General Hospital request to purchase a Vizgen
MERSCOPE. The MERSCOPE is a new technology for multiplex measurement of up to 550 genes in tissue
from any organism, including human. The technology offers exceptional accuracy, reproducibility, and
dynamic range, and permits measurement at true single cell resolution, with an established preparation
protocol. It is thus complementary to standard RNA FISH and enables measurement of hundreds instead of 4-
12 transcripts in tissue sections. In particular, the faculty will use the Vizgen MERSCOPE to carry out
unprecedented and foundational studies to decipher cell type and state localization and cell-cell
interactions in a diverse set of diseases. Preliminary data using an instrument at Vizgen demonstrated that
this technology generates quantitative, highly reproducible data that map well back to our single cell RNA-
sequencing dataset from colorectal cancer, and reveals cell-cell interactions at single-cell resolution. The
MERSCOPE will be operated and maintained in the MGH Cancer Center / Molecular Pathology Confocal Core
Facility, where it will be accessible to all the Major and Minor Users, as well as to a wider community of
researchers from MGH and neighboring Boston institutions. The staff member who will be primarily responsible
for the MERSCOPE is the manager of the microscopes and imaging instruments at the MGH Cancer Center
and has extraordinary expertise in imaging technologies and computation. She is available to operate and
maintain the system and to instruct new users. This new equipment will enable cutting-edge research efforts
supported by major NIH grants, including the NIH DP2 Innovator awards and U54, P01 and R01 projects. It will
provide transformative capabilities for single cell spatial transcriptomics to a community of trainees and
researchers at the MGH and beyond. Finally, it will help establish general methodologies for the use of spatial
genomics technologies applicable in all organisms and across human health and disease.
1

Public health relevance
The proposed research addresses how systems of cells localize and interact in tissues to carry out functions and impact disease. Rather than investigating one or a few genes, we will dissect entire gene networks using an instrument that can quantify expression of hundreds of transcripts at once in a large tissue section.